Center for the Study of Adolescent Risk and Resilience

This revised renewal application proposes the continuation of the Center for the Study of Adolescent Risk and
Resilience (C-StARR) at Duke University. Initially funded in 2008, the Center supports innovative
interdisciplinary research on self-regulation and drug use in late adolescence and early adulthood. Our
application for continuing funding as a NIDA P30 Core Center of Excellence (PAR-18-225) describes an
ambitious research agenda addressing the role of biological and contextual factors in the development of self-
regulation as it relates to drug use and other consequential behaviors. We propose significant new investments
in the collection of contextual data to supplement biological, behavioral, and administrative data in ongoing
studies, thereby extending their potential impact. In order to achieve an overall goal of informing practice and
policy, the work of the C-StARR will be guided by three specific aims. First, through its research support cores,
the C-StARR will enhance the sampling, measurement, methods, and analyses of ongoing studies of
adolescent self-regulation and substance use. Second, through pilot studies C-StARR investigators will
formulate and test novel hypotheses about the interplay of self-regulation and adolescent substance use and
abuse. Third, support staff and senior scientists will contribute to the training of the next generation of addiction
scientists by including early-career faculty members, postdoctoral fellows, and graduate students in
multidisciplinary research teams. The C-StARR will achieve these aims through four cores. The Administrative
Core will provide scientific leadership, ensure collaboration and synergy across cores and projects, and lead
training efforts. The Contextual Data Acquisition and Analysis Core will support innovative approaches to
acquiring and analyzing data that reflect important features of the contexts in which adolescents and young
adults make decisions and behave. The Biological Data Acquisition and Analysis Core will support the addition
of biomarkers and other biological data to ongoing and pilot research studies by C-StARR project teams. The
Pilot Research Project Core will provide funds for focused research and feasibility studies conducted by
multidisciplinary teams of investigators comprising senior- and early-career scientists as well as pre- and
postdoctoral trainees. The C-StARR will serve as a national resource for prevention scientists, intervention
specialists, and policy makers.

Public health relevance
The costs to society of the use and abuse of alcohol, tobacco, and other drugs are among the highest of all conditions targeted by NIH. The center will address this major public health concern by supporting an interdisciplinary team of behavioral scientists to conduct innovative research on the causes and consequences of substance use during late adolescence and emerging adulthood, the period when substance use becomes costly.